Defining the role of GPX3 in Eosinophilic Esophagitis

1 This research proposal investigates the role of Glutathione Peroxidase 3 (GPX3) in regulating
2 esophageal epithelial remodeling, subepithelial fibrosis, and eosinophil recruitment, all histologic
3 features characteristic of Eosinophilic Esophagitis (EoE). In order to maintain esophageal
4 epithelial homeostasis, reactive oxygen species (ROS) might be tightly regulated, and GPX3 is
5 crucial in this process as it catalyzes the reduction of ROS. We have demonstrated that in the
6 esophagus, GPX3 is expressed most highly in differentiated epithelial cells but is also expressed
7 by fibroblasts. In patients with EoE, GPX3 is reduced in these same cell types as compared with
8 non-EoE controls, and IL-13, which induces a large percentage of the epithelial transcriptional
9 changes in EoE, reduces GPX3 and glutathione peroxidase enzymatic activity in epithelial cells.
10 Consistent with these observations, the esophagus of Gpx3-/- mice exhibits histologic features of
11 EoE, including increased basal cell thickness, epithelial proliferation, expansion of transitioning
12 cells, and subepithelial fibrosis. Similarly, Gpx3-/- three-dimensional ex vivo esophageal organoids
13 phenocopy the same epithelial changes seen in mice. Additionally, we have shown that a
14 reduction in GPX3 results in increased susceptibility to activation of signaling pathways central to
15 EoE pathogenesis. Knocking down GPX3 in an esophageal epithelial cell line results in increased
16 activation of STAT6 after IL-13 treatment, suggesting that GPX3 dampens immunoactivation and
17 reduces eosinophil recruitment. Gpx3-/- esophageal organoids and fibroblasts both secrete
18 increased TGF-b1 as compared with wild-type (WT), and organoid culture media from Gpx3-/-
19 results in increased contraction of WT fibroblasts suspended in collagen. Collectively, these data
20 suggest that both epithelial and fibroblast GPX3 may contribute to subepithelial fibrosis through
21 activation of the TGF-b1 pathway. This is important not only because TGF-b1 is a significant driver
22 of fibrosis in EoE, but also because it suggests that the epithelium and subepithelium may be a
23 critical source of TGF-b1 in addition to immune cells. While it is clear that GPX3 is important in
24 regulating esophageal epithelial and subepithelial phenotypes, what is unclear is the mechanism
25 underlying how GPX3 alters these processes critical for EoE pathogenesis. Thus, the aims of this
26 proposal are 1) to determine the mechanism by which GPX3 regulates epithelial remodeling, 2)
27 to dissect how GPX3 regulates eosinophil recruitment and subepithelial fibrosis, and 3) to
28 leverage this information as a therapeutic for EoE. By uncovering a deeper understanding of the
29 molecular function of GPX3 and its regulatory networks, we will discover fundamental insights
30 into EoE pathogenesis, offering potential therapeutic strategies.

Public health relevance
PROJECT NARRATIVE Eosinophilic Esophagitis (EoE) affects more than 150,000 children and adults in the United States, and the incidence and prevalence are both rising. GPX3 is a protein that neutralizes reactive oxygen species (ROS) and is reduced in patients with EoE. While it is known that increased ROS is associated with EoE, it is not known how the formation of ROS is regulated in EoE; thus, we propose to investigate the underlying mechanisms behind how GPX3 contributes to EoE pathogenesis with the aim of identifying new EoE therapeutics.